EFFECTS OF DECREASED HYPERINSULINEMIA ON THE OVULATORY RESPONSE TO CLOMIPHENE

To determine if patients with chronic anovulation due to polycystic ovarian syndrome who are clomiphene resistant will have an improved ovulatory response to clomiphene with correction of hyperinsulinemia.